Optimization of peripheral blood mononuclear cell (PBMC) processing for robust downstream functional immune cell analysis and correlation with therapeutic efficacy

There is an increasing dependence on sophisticated biomarker development to allow prediction of
therapeutic response as well as detection of potential underlying drug targets for novel therapeutics. A frequent
limitation for solid tumors is that standard tissue biopsies are not always feasible, safe or easily repeated during
treatment. Optimal sample acquisition, processing, and final validation are critical for any biomarker, regardless
of source. Moreover, with the advent of immunotherapy, repeated sampling has become even more critical
to understand the tumor and systemic immune response to better predict response and prevent resistance.
Accordingly, there is an urgent need to develop reliable and valid alternatives to tissue biopsies. Peripheral
blood is easy and safe to obtain and is more readily obtainable before, during, and after treatment. Peripheral
blood mononuclear cells (PBMCs) can be isolated from standard whole blood and subsequent isolation and
analysis of protein, DNA and RNA has the potential to serve as a surrogate for tissue response to anti-cancer
therapy. However, analysis of immune functions more reflective of the systemic and tumor immune response to
immunotherapy, using PBMCs, requires unusually rigorous processing techniques. We have found, for
example, that reproducible viability of fresh samples is important for functional responses including cellular
cytotoxicity and chemotaxis. However, fresh processing with subsequent analysis often requires flexible staffing
and constant instrumentation availability due the unpredictable timing of patient sample collection. Furthermore,
requiring immediate analysis may preclude the benefits of batching samples. The central hypothesis of this
proposal is that optimizing PBMC processing will allow for delayed and more comprehensive, reproducible
functional analyses that reflect the patient immune and tumor status permitting clinical treatment decisions
without the requirement of a tissue biopsy.
The hypothesis will be tested by first determining the optimal collection, processing and storage
conditions that maximize long-term viability and sustain intact downstream meaningful functional immune
analyses even when performed in a delayed batch manner. Second, we will determine if the reproducible PBMC
functional outcomes serve as a surrogates to tumor infiltrating immune cell function and therapeutic efficacy.
This approach will allow the advancement of peripheral blood biospecimens to reflect underlying
mechanisms of tumor behavior previously relegated to the invasive tissue biopsy. In addition, we will have
established conditions for processing PBMCs that allow for reproducible collection of viable cells that maintain
functional capacity upon storage, from which meaningful functional assays can be performed by different
facilities. The fundamental knowledge obtained from this proposal will facilitate the development of suitable
correlative PBMC analyses for future clinical trials allowing for an easily obtained patient specimen that can
determine treatment and clinical responses in real time to immunotherapy and other anti-cancer therapy.

Public health relevance
As conventional tissue-based biomarkers are limited by availability, safety, and patient considerations, and most current blood-based biomarkers do not accurately assess tumor or immune microenvironment status, there is an urgent need to develop new biomarkers that not only aid in the choice, but also predict response to immunotherapy and other anti-cancer treatments. Recent studies suggest that cytotoxic T and natural killer cells isolated from peripheral blood mononuclear cells (PBMCs), may, if processed appropriately, provide a blood- based biomarker that could substitute for a routine biopsy and more closely reflect both the systemic and tumor immune response. The purpose of this proposal is to optimize the processing of these easily attainable blood samples and demonstrate that under these optimal conditions, they can be utilized as biomarkers and improve patient-specific treatment choices by predicting outcomes as a surrogate to, as well as complement, the standard tissue biopsy.